Role of OT and Ach in enhancing social discrimination by modulating rat amygdalo-striatal networks

Project Summary (Project 3, Rainnie)
The ability to recognize the identity and intentions of others and to react accordingly is an evolutionarily adaptive
process with relevance to psychiatric disorders. However, the cellular and neurotransmitter systems that regulate
this process remain largely unknown. One region consistently shown to play a pivotal role in regulating the
behavioral response to both appetitive and aversive sensory and/or social stimuli is the basolateral amygdala
(BLA). The activity of neurons in the BLA has been shown to signal preference in a social recognition task, and
in the previous Conte Center funding period we showed that during social interaction between same sex rats
neural activity in the BLA and a key component of reward circuitry, the nucleus accumbens (NAc), became highly
synchronized. Synchronization was associated with markedly enhanced θ-γ cross-frequency-coupling (θ-γ CFC)
similar to that seen in non-human primates (NHP) during performance of a social preference task (see Project
4) and between the mPFC and NAc during pair bonding in voles (Project 2). Together, these data suggest that
θ-γ CFC may represent a canonical mechanism for integrating executive, emotion, and reward circuits to drive
appropriate behavioral responses during social interaction. We have successfully developed a novel rat social
recognition task, which mirrors the task being utilized in the NHP studies of Project 4, and with which we can
directly examine the role of two neurotransmitters, acetylcholine (ACh) and oxytocin (OT) in the modulation of
social recognition as well as θ-γ CFC in the pathway from the BLA to the NAc. These two neurotransmitters have
been shown to play key roles in regulating cue discrimination, θ-γ CFC, and social interaction in rodents and
NHPs. However, ACh and OT are usually studied independently of one another. It is our contention that ACh
and OT act synergistically in the BLA to facilitate social recognition in conspecifics. Here, we will test the
hypothesis that OT release in the BLA acts to facilitate social recognition by enhancing ACh release in the BLA
and promoting θ-γ CFC in the pathway from the BLA to NAc. To challenge this hypothesis we will use state-of-
the-art gene transfer and gene deletion techniques in conjunction with pathway specific viral vector manipulations
to selectively target specific neural circuits that are thought to regulate BLA neural activity during social
recognition and discrimination. The PI of Project 3, is an internationally recognized expert in the field of amygdala
anatomy and physiology and has a track record of using state-of-the-art viral vector manipulations to examine
the fine structure of neural circuits that regulate affective behavior. In addition, the research team for Project 3
have all of the necessary expertise to successfully complete the proposed studies. We anticipate that at the end
of Project 3 we will have markedly increased our understanding of the interaction between two critical
neurotransmitter systems that are known to play a major role in social discrimination. By better understanding
the systems and circuits that guide prosocial behavior we will be able to develop more targeted therapeutic
approaches for disorders that share a common pathology of deficits in social behavior.